Continuous calcium sensor patch for hypoparathyroid patients

PROJECT SUMMARY
Hypoparathyroidism (hypoPT) is a disease characterized by absence of circulating parathyroid hormone
(PTH), the major hormonal regulator of extracellular calcium homeostasis. Symptoms of hypocalcemia range
from tingling and muscle cramps and neuropsychiatric symptoms to seizures and life-threatening
laryngospasm. Treatment with calcium and vitamin D partially relieves symptoms of hypocalcemia, but can
also “over-shoot,” leading to episodes of hypercalcemia, which, in the absence of the renal calcium-conserving
effect of PTH, lead to renal parenchymal calcification and long-term irreversible renal damage. Indeed, chronic
kidney disease is found in 41% of hypoPT patients and is directly associated with the proportion of time with
hypercalcemia.
As such, even with today’s best practices, the daily levels of calcium fluctuate down and up, resulting in
hypocalcemia and hypercalcemia, with serious and irreversible organ damage and mortality. HypoPT patients
would benefit greatly from knowing their calcemic variability in real time, giving them a chance to adjust their
treatment individually and dynamically. We propose to develop a sensor patch technology featuring
biocompatible “hydrogel microfilaments” that can penetrate the skin while allowing for in situ optical
fluorescence sensing of analytes in dermal interstitial fluid. The non-hollow structure of the microfilaments
allows for easy fabrication, the porous nature of hydrogels ensures that calcium in interstitial fluid can diffuse
into the filaments, the large internal surface of hydrogel allows for analytes to interact with a large number of
conjugated fluorescent aptamers for signal generation, and optical transparency allows for in situ optical
sensing with a wearable fluorometer with no fluid extraction needed.
Our central hypothesis is that a skin patch with hydrogel microfilaments can enable repeated in vivo
calcium sensing. Upon completion of these aims, the expected outcome is a full characterization of the
performance and limits of a microfilament-based continuous sensor of calcium, and demonstrations of in vivo
sensing in a live rat model and in the interstitial fluid of human subjects. These results are expected to have an
important positive impact because they will provide a strong proof of principle for clinical testing of a continuous
calcium sensor, ultimately providing new opportunities for individualized treatment of patients with hypoPT to
maintain calcium homeostasis and reduce irreversible kidney damage and deadly laryngospasm. More
broadly, this project will propel this minimally invasive sensing technology a step forward towards the rapidly
approaching new paradigm of precision monitoring and medicine.

Public health relevance
PROJECT NARRATIVE This project will develop and characterize a wearable, continuous calcium sensor for patients with hypoparathyroidism to maintain calcium homeostasis and reduce irreversible kidney damage and deadly laryngospasm.